Multidisciplinary Training in Alzheimer and Related Dementias

ABSTRACT/SUMMARY
The Washington University “Multidisciplinary Training in Alzheimer and Related Dementias” (ADRD-T32)
Training Plan is designed to train the next generation of translational researchers in Alzheimer disease and
related dementias (ADRD). The program will be led jointly by the Knight ADRC and the Hope Center for
Neurological Disorders at Washington University School of Medicine (WUSM). The focus of the program is
on multidisciplinary team-based research that accelerates the development of treatments for ADRD and
increases diversity in the research workforce by enhancing the clinical and translational basic science
experience for young investigators in a highly enriched research environment. The Knight ADRC and the
Hope Center support a highly collaborative environment that exemplifies multi-disciplinary team-based
research. Thirty-three faculty from twelve Departments at Washington University will mentor trainees in
dementia research. The faculty include basic scientists, translational neuroscientists and clinical
investigators. WUSM has outstanding resources, including state of the art facilities for translational
research, biostatistics and informatics, and an excellent track record in developing new therapies. The
predoctoral students will be drawn from 9 different doctoral programs, including those affiliated with specific
departments (Biomedical Engineering, Psychological and Brain Sciences, and Social Work) as well as from
programs in the Division of Biology and Biomedical Sciences, including Biochemistry, Computational and
Systems Biology, Developmental, Regenerative and Stem Cell Biology, Human and Statistical Genetics,
Molecular Genetics & Genomics, Neuroscience and from the McKelvey School of Engineering.
Postdoctoral trainees will be drawn from Chemistry and Developmental Biology, clinical departments
(Neurology, Medicine, Pathology, Psychiatry and Radiology), Biostatistics, Psychological and Brain
Sciences and the School of Social Work. The training program will support 3 predoctoral trainees and 3
postdoctoral trainees; each year the program will support 2 medical students from Meharry Medical College
School of Medicine for a short-term training program aimed at exposing promising medical students to the
field of ADRD early in their medical training. The program will provide training (but no stipend) for two
Washington University School of Medicine medical students participating in the Year Long Research
Program. The training program includes sessions devoted to clinical aspects of dementia, datasets and
resources available at the Knight ADRC, WUSM and through large national efforts, bioinformatics, and
responsible conduct of research. The program aims to develop a pipeline of diverse and rigorously trained
ADRD researchers through mentorship with leading experts in all facets of ADRD research from a leading
center with over 4 decades of success in training AD researchers.

Public health relevance
PROJECT NARRATIVE The Washington University T32 training grant “Multidisciplinary Training in Alzheimer and Related Dementias” (ADRD-T32) is designed to prepare the next generation of researchers in Alzheimer disease and related dementias. The program provides training in collaborative, multidisciplinary research for predoctoral and postdoctoral trainees from a variety of disciplines, emphasizing translational research and utilization of large scale NIH-supported data sets.